Measuring treatment response and residual disease in leukemia with personalized, sensitive, and quantitative genomic methods

Project Summary
To improve patient outcome in cancer, better methods are urgently needed to measure therapeutic response
and detect early relapse. In acute myeloid leukemia (AML), 50% of patients in remission will relapse within 2
years. Current methods lack the sensitivity and generality to detect minimal residual disease (MRD) in all of
those patients. Multiplex Accurate Sensitive Quantitation (MASQ), is both sensitive and general. It can target up
to 50 patient-specific mutations, with sequence error rates reduced to 1 in 1 million, and count mutant DNA
molecules with molecular tags. In a pilot study of AML, MASQ detected somatic variants at levels ranging from
1 in 100 to nearly 1 in 1 million, with higher mutation frequencies in patients who relapsed. There is also a critical
need to interpret minimal residual disease in the context of pre-leukemic clonal hematopoiesis and the evolution
of leukemic cells. Relapse may arise from drug-resistant leukemic cells, a genetically diverged subclone, or a
reservoir of pre-leukemic stem cells. In this proposal, I apply and improve innovative genomic tools for measuring
treatment response, predicting clinical outcome, and investigating the nature of residual cells in AML.
This project utilizes a large observational clinical study of AML to track patient-specific leukemia-associated
variants in blood samples taken over the course of the disease. Aim 1 will analyze subclonal treatment response
and the dynamics of relapse by tracking leukemia-associated variant allele frequencies across time. Aim 2 will
establish the prognostic value of a personalized, highly sensitive, and quantitative test for residual disease in
AML. Aim 3 proposes to isolate the rare residual cells harboring leukemia-associated variants from a remission
blood sample to determine the genomic and transcriptomic profiles that may provide further biological and clinical
insight into the disease.
I have proposed a tailored career development plan that will prepare me for my transition to independence.
Following my postdoctoral fellowship training, I aim to be an independent tenure-track professor at a major
research university. The training environment at Cold Spring Harbor Laboratory (CSHL) provides access to
world-renowned meetings and courses, and a plethora of investigators with expertise in cancer and quantitative
biology. My professional development activities center around mentorship, communication, teaching, lab
management, and preparing for the academic job search. My training will also include coursework in clinical
translation and single cell analysis; presentations at conferences in genome informatics, cancer biology, and
liquid biopsy; and mentored research goals under the guidance of my mentor Dr. Michael Wigler and my co-mentor Dr. Dan Levy. I have assembled a team of additional scientific advisors and collaborators including Dr.
David Tuveson and Dr. Christopher Vakoc from CSHL and Dr. Steven Allen from Northwell Health.

Public health relevance
Project Narrative Better methods are urgently needed to measure therapeutic response and detect early relapse, especially in acute myeloid leukemia (AML), where 50 percent of patients that have a complete response to initial treatment go on to relapse within 2 years. Current methods for measuring minimal residual disease in AML are not sensitive enough, do not apply to all patients, and do not fully capture the genetic heterogeneity of the disease. In this project, we propose that utilizing personalized genetic mutations associated with a patient’s leukemia will result in more sensitive, quantitative, and general measurements of minimal residual disease, allowing for better evaluation of treatment efficacy and earlier detection of relapse, ultimately improving patient outcome in AML.